Investigating Donor Human Milk Composition Globally to Develop Effective Strategies for the Nutritional Care of Preterm Infants

Project Summary
Globally, almost 15 million infants are born prematurely each year, disproportionately affecting low and middle-
income countries. In the absence of mother’s milk (MOM), the World Health Organization and the American
Academy of Pediatrics recommend using donor human milk (DHM) due to its protective effect against
necrotizing enterocolitis, a life-threatening intestinal infection. In response to these recommendations,
development of donor milk banks and the use of DHM is increasing globally, with many low and middle-income
countries integrating donor milk banks into their public health strategies to reduce neonatal mortality. It is
estimated that 800,000 infants globally receive DHM each year, yet very little is known about the nutritional
composition of DHM; how composition is influenced by milk banking practices; and whether preterm nutrient
recommendations are achieved when DHM is used with commercially available fortifiers. There is evidence
that preterm infants fed DHM have inferior growth rates compared to infants receiving preterm formula or
mother’s milk, even when multi-nutrient fortifiers are used, suggesting suboptimal nutritional support
(macronutrients, micronutrients, or both). To develop effective nutritional therapies for the increasing number of
preterm infants globally receiving DHM, evidence-based nutritional standards for DHM are urgently needed.
Studies to-date on DHM composition have typically been small (< 50 samples) and represented milk from a
single milk bank in a high-income setting, which may be different from DHM from milk banks in low-income
settings. Additional limitations include the dearth of studies on vitamins, minerals, and bioactive factors, and
the use methods that may overstate protein and lactose values. This proposal seeks to address these research
gaps in global preterm infant nutrition by conducting a multi-site study with eight geographically diverse milk
bank partners in high, middle, and low-income settings. We will examine and compare a broad range of
nutrients in milk from 600 approved milk bank donors around the world to create comprehensive,
geographically diverse nutrient profiles for DHM (Aim 1). Milk bank-level practices for pooling donors will be
evaluated using simulation to identify effective strategies that can be used by milk banks to create more
consistent nutrient profiles in DHM (Aim 2). Finally, we will evaluate whether currently available commercial
fortifiers meet nutrient recommendations when used with DHM and will identify nutrients to enhance in the
development of a DHM-specific fortifiers (Aim 3). The long-term goal of this study, designed in response to
RFA-HD-21-006, is to improve preterm nutritional care globally for the growing number of infants who receive
donor human milk.

Public health relevance
Project Narrative While donor human milk protects preterm infants from life-threatening gut infections, it is also associated with poor in-hospital growth, which can have long-term developmental consequences. Almost a million infants globally are fed donor human milk, yet there is limited information about the nutritional and energy composition of donor milk and how this is influenced by milk banking practices and commercially available fortifiers. This study seeks to fill these gaps in the literature through a collaboration with eight geographically diverse milk banks globally that will characterize the composition of nutrients in donor milk and explore how milk banking practices and commercial fortifiers influence the nutritional care of infants who are fed donor human milk.